Development of a multiplexed assay in kinetoplastid parasites to identify probes for glycolysis

Project Summary/Abstract
Parasite infection with members of the class Kinetoplastea, including Trypanosoma brucei and Leishmania spp.,
places a tremendous burden on human health, with an estimated ~1.4 million cases of disease recorded in 2015
(World Health Organization). Despite the widespread impact of these organisms, there remain major gaps in our
understanding of fundamental parasite biology. For example, it is appreciated that glucose is a critical metabolite
that can also serve to regulate important developmental pathways in the parasites. However, our understanding of
these areas, particularly in the context of living parasites, is extremely limited.
We propose to elucidate key mechanistic aspects of kinetoplastid glucose metabolism in kinetoplastids using a
validated, yet unprecedented, screening assay platform based on live parasites expressing protein sensors that
measure glucose uptake, distribution, and metabolism. We will adopt these cells to a novel and effective
multiplexed high-throughput screening assay to identify small molecule probes that disrupt glucose uptake,
distribution and metabolism in live parasites. This unique approach will simultaneously identify inhibitors of
glycolysis that possess chemical properties required for delivery to the cellular target. Hits from the screening of a
structurally diverse 100,000 compound collection will be validated by resynthesis, reconfirmation and counter-
screening. Target identification, which will be facilitated by mapping the impact of the inhibitor on the pathway
using the read-out from the assay, will be confirmed using reverse genetic and proteomic approaches. Last, the
identified small molecule glycolytic probe inhibitors will be improved by SAR and their activity against parasites
scored. Expected outcomes include development of a screening strategy that will be applicable to many types of
cells, along with the identification of validated probes that dissect an essential parasite metabolic pathway.

Public health relevance
PROJECT NARRATIVE Work proposed here will combine genetically encoded biosensors in a multiplexed screening assay in live cells to identify small molecule probes capable of inhibiting glucose uptake and metabolism in kinetoplastid parasites in order to develop tools for exploring this important yet incompletely understood metabolic pathway. The proposed work is impactful, as it will pioneer a new self-validating screening methodology that will yield useful tools for understanding glucose metabolism at the cellular level in a group of important early-branching eukaryotes and could also be adopted for use in other organisms. Additionally, outcomes from the research have the potential to advance treatment of neglected tropical diseases that, in some cases, have currently inadequate therapies.